Structural Biology Core

Summary for the Structural Biology Core (Core B) led by Core Director Eric Enemark, PhD
Our understanding of cancer biology and the development of novel therapeutics both rely on an atomic-level
understanding of the biomolecular structures and the dynamic interactions that govern function. The COBRE
Center for Molecular Interactions in Cancer (CMIC) will leverage available resources, expertise, and
institutional support to create a new Structural Biology Core (Core B) that is essential for the research mission
of the Center—namely, studying the structural features of biomolecules that impact their function in cancer. This
core will be directed by Eric Enemark, PhD, nationally recognized as a leader in the field of structural biology.
This new core does not duplicate existing core facilities or shared resources at the University of Arkansas for
Medical Sciences (UAMS). It will have experienced staff and state-of-the-art equipment. Our major goal during
Phase 1 is to provide highly-specialized support and educational opportunities to current and future CMIC
Research Project Leaders (RPLs), as well as other Center members, for studies that use structural approaches
to investigate biomolecules implicated in the etiology of cancer. To achieve this goal, we will pursue 3 Specific
Aims. In Aim 1, we will establish a new core facility for advanced structural biology, especially X-ray
crystallography and cryo-electron microscopy (cryo-EM). In Aim 2, we will deliver state-of-the-art services for
CMIC RPLs, including collection, analysis, and interpretation, as well as assistance in the visualization and
reporting of the results. In Aim 3, we will provide training and education related to structural methodologies and
quantitative analysis of biomolecules, extending our efforts outwards from the CMIC to the broader research
community at UAMS and other campuses in Arkansas. An important long-term goal is to create a self-sustained
core by establishing a recharge mechanism and serving as a resource in future program project grants submitted
by CMIC investigators. The Structural Biology Core fits squarely within the theme of the Center as it will facilitate
rigorous and technically challenging investigations of macromolecules, complexes, and processes that drive
tumor malignancy and the pathways that influence therapy resistance.